Advancing the clinical actionability of polygenic scores for coronary artery disease

PROJECT SUMMARY/ABSTRACT:
Coronary artery disease (CAD) remains the leading cause of death globally and the identification of
individuals at high risk to target early prevention strategies is a major public health need. Commonly used
clinical risk estimators are validated for limited age and ancestry groups and are poorly calibrated to
contemporary populations, limiting their utility. Polygenic scores (PGS) – which quantify inherited risk by
summing information from many common sites of DNA variation – hold considerable promise for improving
upon available clinical risk estimators, however available PGS for CAD currently lack proper actionability
due to limitations of input data, score methodology, and clinical applications. More comprehensive and
equitable tools incorporating genetic risk are needed to predict risk earlier in life to enable preventive
interventions and reduce morbidity and mortality of CAD. Dr. Patel proposes to develop more generalizable
PGS for CAD using multi-ancestry genomic data; to construct clinically interpretable, absolute CAD risk
prediction models integrating genetic and non-genetic factors; and to investigate new clinical indications for
PGS use utilizing clinical trial data. In Aim 1, Dr. Patel will develop new PGS for CAD optimized for
individuals of diverse ancestries by harnessing the principle of burrowing information from functional
genomic annotations, cross-ancestry correlation, and cross-trait correlation to refine the effect estimates of
genetic variants included in these scores. In Aim 2, Dr. Patel will integrate polygenic risk with clinical risk
factors to develop a absolute risk prediction models for CAD, which he will then calibrate, validate, and
deploy in external datasets. In Aim 3, Dr. Patel will define clinical use indications for PGS using secondary
analyses of CAD prevention clinical trials within the context of individuals with inflammatory mediators
including HIV and elevated C-reactive protein. The overall goal for this application is to advance the
actionability of PGS by addressing their limitations in equity, interpretability, and indication. Upon successful
completion of these aims, Dr. Patel expects to deliver better-performing and cross-ancestry portable CAD
PGS, share externally validated, integrated absolute risk prediction models, report utility for PGS use in
specific sub-populations for guiding therapies, and nominate inflammatory mechanisms to target in future
trials. These endpoints will collectively advance the actionability of PGS models for CAD, moving closer to
their clinical deployment for disease prevention. This research will be accomplished in the setting of a
comprehensive career development program designed to provide Dr. Patel with the skills needed to
become an independent physician-scientist in cardiovascular genomics. This proposal brings together a
unique interdisciplinary advisory team of experts in the fields of epidemiology, genomics, statistics, and
clinical trials research that will guide Dr. Patel in his transition to scientific independence.

Public health relevance
PROJECT NARRATIVE: Earlier identification of individuals at high risk for coronary artery disease is needed to allow for initiation of prevention strategies to reduce morbidity, mortality, and healthcare costs. Polygenic scores, which can estimate an individual’s genetic predisposition for disease early in life, have the potential to advance risk prediction beyond current methods based solely on clinical factors. This proposal seeks to combine newly available data and statistical methods to advance the actionability of polygenic scores by improving their performance across diverse ancestral groups, making them more interpretable in the clinical setting, and identifying new uses for them in guiding preventive therapies.